Plan to Enhance Diversity

PROJECT SUMMARY/ABSTRACT - PLAN TO ENHANCE DIVERSITY
Longstanding national efforts aimed at increasing diversity in the biomedical workforce have had only
incremental impact. Similarly, we recognize that the racial demographics of the University of Chicago Medicine
Comprehensive Cancer Center (UCCCC) are not reflective of either our catchment area or the national
population demographics. We are fundamentally committed to changing this characteristic, and to this end, in
2021, UCCCC established the Office of Diversity, Equity, and Inclusion (DEI) and launched a 5-year DEI
Strategic Plan that aligns to the Plan to Enhance Diversity (PED) Program and focuses on infrastructure,
people, climate, and community. The goal of the UCCCC PED is to achieve the full potential of diversity in our
cancer workforce by actualizing meaningful and sustainable systemic cultural change, instituting a career
advancement cohort model, establishing strong community networks, and training transformative diverse
scholars who will reduce the burden of cancer. Central to the PED Program is synergizing with Community
Outreach and Engagement Component and the Cancer Research Training and Education Coordination
(CRTEC) Component to build bidirectional partnerships with our local communities because engaging diverse
groups in our basic, clinical, translational, and population research activities accelerates our discoveries and
impacts communities in our catchment area. Along with CRTEC, we are establishing training and mentoring
opportunities to encourage students, post-doctoral fellows, and faculty from diverse backgrounds to expand the
pipeline of cancer researchers. Guided by a logic model, the UCCCC will operationalize three aims to achieve
the PED goals: (1) building environmental capacity to enhance diversity by implementing processes and policies
focused on climate and recruitment in the cancer center; (2) developing career advancement capacity to increase
underrepresented minorities and women in UCCCC leadership; and (3) establishing community networks to
enhance diversity of cancer center staff, members, and leaders. To accelerate the impact of the PED, the
UCCCC has already invested in structural and personnel infrastructure, new initiatives, dedicated financial
resources, and fully integrated DEI into all UCCCC programs and the executive leadership. PED will establish
criteria for monitoring and evaluating progress in diversity. Transformative impact in DEI requires bold steps; the
UCCCC has invested in infrastructure to support transformative change in our Cancer Center and the PED
provides a clear path forward for actualizing the full potential of diversity, equity, and inclusion.